Communicating about Nicotine and Differential Risks of Tobacco Products in Priority Populations

ABSTRACT
Tobacco use continues to disproportionately harm priority populations, such as smokers with mental health
conditions and people from low socioeconomic status (SES) groups. The US Food and Drug Administration
(FDA) is moving forward with a groundbreaking plan to reduce tobacco-related death and disease by lowering
nicotine in combusted cigarettes to minimally addictive levels. To maximize the effectiveness of this potentially
life-saving policy, its implementation needs to be accompanied by messages that address misperceptions
about very low nicotine cigarettes (VLNCs; e.g., that VLNCs are less harmful than regular cigarettes). Past
randomized clinical trials (RCTs) with VLNCs found that they are less addictive than cigarettes, reduce the
number of cigarettes smoked per day, and have similar beneficial effects among priority populations as in the
general population. However, past RCTs with VLNCs did not include messages about the products or policy.
Emerging studies have begun to investigate messages about VLNCs, but so far they did not examine the
effects of messages on behavior and were all hypothetical, with messages unaccompanied by use of the
actual product. We propose to take the next step and bring together two streams of research (RCTs of VLNCs
and messages about VLNCs) that have remained disparate but need to be combined to more closely resemble
reduced nicotine policy implementation in the real world. We will address three specific aims: (1) Develop
targeted messages about reduced nicotine in combusted tobacco products for smokers with serious
psychological distress (SPD) and socioeconomically disadvantaged smokers using qualitative focus groups.
(2) Test the impact of messages about VLNCs on tobacco use behaviors in an RCT with smokers with SPD,
low-SES, and smokers who are neither. After 1-week baseline using normal nicotine content cigarettes,
participants will be randomized into treatment (VLNCs and messages) or control (VLNCs only) condition.
Participants in the treatment condition will be exposed to messages as inserts (small printed leaflets) in
cigarette packs and print and video ads during weekly in-person visits. All participants will use VLNCs for 4
weeks and complete daily logs and weekly in-person visits. (3) Assess experiences with VLNCs and messages
among the RCT participants in focus groups following the completion of the RCT. The results will contribute to
the science that informs FDA regulatory actions around product review, product standards, and public
education on nicotine.

Public health relevance
PROJECT NARRATIVE The US Food and Drug Administration (FDA) is moving forward with its groundbreaking plan to reduce tobacco-related death and disease by lowering nicotine in combusted cigarettes to minimally addictive levels. To maximize the benefits of this potentially life-saving policy, we developed messages about reduced nicotine and the health risks of using different tobacco products. We will test the effects of these messages on behavioral outcomes in priority populations in the context of using very low nicotine content cigarettes, approximating the initial implementation of a national nicotine reduction policy accompanied by a communication campaign.